Control of Translation in Herpesvirus Infected Cells - Resubmission - 1

7. PROJECT SUMMARY / ABSTRACT
Regulation of gene expression at the level of translation allows cells and organisms to respond swiftly to
physiological stress and changing environments. Indeed, differential translation of capped, polyadenylated
mRNAs by eukaryotic ribosomes plays a critical role in biological processes vital for human health, including
normal cell growth, differentiation, development, learning and memory, and responses to physiological stress
including virus infection. Viral model systems have proven useful in elaborating cellular translational control
strategies because their replication is absolutely reliant upon virus mRNA translation by host ribosomes. Here,
we utilize a herpesvirus family member, human cytomegalovirus (HCMV), to probe the complex circuitry
regulating mRNA translation. Although innocuous in healthy individuals, HCMV is a widespread, opportunistic
pathogen responsible for severe disease among the immunocompromised, including organ transplant
recipients and AIDS patients. In addition, congenital HCMV infection is the leading viral cause of birth defects
in newborns. Our long-term overall objective is to understand the mechanism(s) through which HCMV
manipulates the cellular translational machinery to control viral replication. A fundamental step
regulating protein synthesis in HCMV-infected cells involves ribosome recruitment to the 5'-end of m7G-capped
virus and host mRNAs. This typically involves 5'-cap-recognition by a translation initiation factor complex
containing the cap-binding protein eIF4E followed by loading the eIF3-bound 40S ribosome. Unexpectedly, an
alternative form of 40S ribosome loading relying upon cap-recognition by a specific eIF3 subunit, eIF3d, has
been described that bypasses the need for eIF4E and is distinctly regulated. Preliminary results establish that
targeting eIF3d selectively inhibited HCMV replication, reduced polyribosome abundance and interfered with
expression of essential virus late genes and a host gene expression signature indicative of chronic ER stress
that fosters HCMV reproduction. Based on our preliminary results, we hypothesize that eIF3d-dependent cap-
recognition is hijacked to exploit virus-induced ER-stress and switching between eIF4E and eIF3d-responsive
translation differentially tunes virus and host gene expression in infected cells. This hypothesis is tested in
three specific aims designed to: i) determine how HCMV infection impacts eIF3d accumulation and sub-cellular
distribution; ii) define the mechanism whereby eIF3d selectively shapes the gene expression landscape in
HCMV-infected cells; and iii) decipher how eIF3d activity is regulated in HCMV-infected cells. The project is
impactful because how non-canonical translation initiation mechanisms involving eIF3d regulate differential
mRNA translation during stress responses like virus infection remains largely unknown and represents a
significant knowledge gap poised to reveal new biology and therapeutic opportunities for interfering with virus
replication or vaccine development. Furthermore, it will provide insight into fundamental translational control
mechanisms important in human diseases, like cancer and diabetes, where protein production is dysregulated.

Public health relevance
8. PROJECT NARRATIVE Regulated cellular protein production, which plays a critical role in numerous biological processes vital for human health (such as normal cell growth, development, learning, memory and proper response to environ- mental stress) is disrupted in many human diseases, including cancer, diabetes, and viral infections, resulting in significant alterations in protein accumulation. Our studies use human cytomegalovirus (HCMV) as a power- ful model to investigate the complex cellular circuitry that properly regulates protein production. A comprehensive picture of how protein production is controlled could contribute to new strategies of treating many human diseases including those caused by HCMV, which despite being innocuous in most healthy individuals causes severe disease in those whose immune systems are not functioning properly (including transplant recipients along with AIDS patients) and is the leading viral cause of birth defects in newborns.